DP21-003 Reducing Cancer Disparities within the Black community in Jackson, MS through Community-Led Tobacco-Related Social Norm Change

Abstract
This proposal addresses Component A to Reduce Inequities in Cancer Outcomes through Community-Based
Interventions on Social Determinants of Health, through an evaluation of Project BAT (Black people Against
Tobacco), a community-led intervention to empower low-income African American (AA) and Black communities
to change social norms around tobacco utilization and promote optimal health and cancer prevention
throughout the community. The overall goal of Project BAT, implemented in Jackson, MS, is to change the
pervasive social norm that smoking is a coping mechanism used to cope with systemic racism, poverty, and
chronic stress, by conducting authentic community engagement with Community Action Groups (CAG) and a
local anchor organization, My Brother’s Keeper (MBK). Across the nation, and in the South particularly,
AA/Black people are burdened with the pervasive effects of centuries of institutional racism. Not only have
policies such as Jim Crow and redlining created deadly socio-economic environments, but their existence is
upheld by historical trauma and persistent wounds across generations. Traditional and ‘‘outsider driven’’
smoking cessation programs that generally target behaviors at the individual-level have not been effective for
populations with high poverty and who experience systemic racism, segregation, and chronic stress. Latest
research instead recognizes the importance of using community-initiated and engaged approaches to ensure
that local culture and context are central components of programs in order to catalyze meaningful local social
norms change and strengthen policies. To achieve these goals, CAI will conduct capacity building activities
among CAG members and MBK leadership to support their identification and implementation of a series of
phased actions to increase: access to services; resources regarding tobacco cessation and health and well-
being; social media marketing to provide educational messages; and policy advocacy to promote a healthy
tobacco-free environment. Evaluation methods will include a concurrent mixed-methods study design to
conduct a robust formative and process evaluation on implementation and to assess barriers and facilitators of
using community engagement to address social norms change, and a cross-sectional survey conducted
annually using a probability sample of households in intervention and comparison communities to measure the
impact of community-level interventions within general population groups. Measured outcomes will include the
improved social, health, and environmental conditions to allow for social norms change, including social media
and marketing messages, policy changes, and increased access to supportive services that promote health
and well-being in the community. Over time, as social norms change occurs, the community of Jackson will
see improved outcomes in tobacco-related behaviors, including quit attempts, usage, secondhand smoke
exposure, and long-term health outcomes associated with tobacco use.

Public health relevance
Project Narrative Reducing Cancer Disparities within the Black community in Jackson, MS through Community-Led Tobacco- Related Social Norm Change will evaluate Project BAT (Black people Against Tobacco), an ongoing community-led intervention to empower low-income African American and Black communities to change social norms around tobacco utilization and promote optimal health and cancer prevention throughout the community. There is broad understanding of the function of norms around tobacco use as well as what the threshold for “tipping points” of norms generally are, but the impact of using a community-engaged model to drive social norm change among Black and minority communities remains unexamined. Through our proposed rigorous evaluation of Project BAT, which addresses the myriad environmental factors that contribute to tobacco use, we seek to demonstrate to the research community that social norms change is achievable through community-based action.